Admin Core

The overarching goal of the Tri-I TBRU program is to identify the mechanisms that determine TB control, relapse
and reinfection. This work will take advantage of the close integration, high levels of expertise, and history of
successful collaboration among the participating research groups. Careful project management will be essential
to the success of this program consisting of three projects and two scientific cores. The Administrative Core will
provide this project management and is a key component to maximizing efficiency and synergies of our program.
Specifically, the Administrative Core will manage and coordinate the projects and cores of the Tri-I TBRU,
including resource and fiscal management, management of contractual agreements, and problem identification
and resolution; facilitate communication and synergy amongst the projects and ores; and manage and execute
communications to external partners.